Water and chloride movement in neurons during seizure activity

PROJECT SUMMARY/ABSTRACT
There are no pharmacological treatments for cytotoxic edema, which is a common consequence of multiple
brain insults, including hypoxic-ischemic and traumatic brain injury, stroke, metabolic derangements, and
seizures. Hypoxic-ischemic encephalopathy (HIE), with an incidence of 1.5 of every 1,000 live births, is a type of
brain damage in newborns caused by oxygen deprivation and limited blood flow. HIE is associated with seizures,
and both correlate with long-term morbidity, including cerebral palsy, cognitive delay, epilepsy, vision loss, and
deafness. HIE and neonatal seizures result in cytotoxic edema, which is characterized by the accumulation of
water, chloride (Cl-), and other ions. The mechanisms of water movement that make neurons swell during the
neonatal period are unknown. There is a critical need to determine how water moves into neurons that result
and perpetuate neuronal swelling during the neonatal period, as there are no direct treatments for cytotoxic
edema at this age. Knowing the pathways of water movement in neurons is the first step to develop innovative
ways to treat cytotoxic edema, which will prevent neuronal cell death and improve the treatment of neonatal
seizures. Neurons do not have water channels to allow the movement of water. Multiple pathways have been
described in different cell types, but it is unknown which ones participate during the neonatal period. Our long-
term goal is to identify the mechanisms of neuronal swelling in the developing brain and how this swelling results
in neuronal death. Our central hypothesis for this proposal is that specific cation-chloride cotransporters (CCCs)
move water, along with Cl-, in and out of neurons during cytotoxic edema in the neonatal period. This hypothesis
is based on our data demonstrating the linked movement of water and Cl- in neurons during cytotoxic edema.
We will test our hypothesis through two specific aims. Aim 1 will determine the pathway of water movement
into neurons during swelling in the neonatal period. Aim 2 will determine the paths of water movement out of
cortical neurons that prevent progressive swelling during the neonatal period. We will use multiphoton imaging
techniques to measure changes in neuronal size and their Cl- concentration during swelling in different
transgenic mouse lines expressing both Cl- sensitive and insensitive fluorophores, in vitro, and in vivo, while
altering the CCC function either pharmacologically or through genetic manipulation. Also, we will use a novel
deep learning algorithm to analyze the changes in neuronal size during swelling. Our studies will uncover
fundamental mechanisms on how neurons swell and what mechanisms prevent progressive swelling during
early brain development. Our results will have a broad impact as they will open new research avenues on
neuronal volume regulation in the newborn and will guide the development of drugs targeting cytotoxic edema,
which are currently lacking. Moreover, our results will apply to other severe brain injuries in children that are
associated with cytotoxic edema and elevated neuronal Cl- concentration, including trauma, and stroke.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on determining the pathways that lead to water accumulation during cytotoxic edema, a pathological state observed in multiple neurological injuries of the newborn, resulting in cell death and difficult to treat seizures. Once the pathways are identified, there is the potential for significant advancement in the treatment of neuronal swelling, which is currently lacking. The project is relevant to NIH’s mission that pertains to reducing illness and disability.